DOSE RESPONSE PHARMACOKINETIC AND MECHANISM STUDY OF METHOTREXATE IN IBD

The protocol will compare the additive effects of two doses of methotrexate given by subcutaneous injection, in the clinical course of inflammatory bowel disease to see if a certain dose works best. The protocol has been extended with an addendum. We propose in our upcoming experiments to determine if treatment with methotrexate, and other anti-inflammatory drugs, inhibits the immune function of cultured intestinal epithelial cells at the level of secretion of soluble mediators inflammation, pro-inflammatory intercellular signaling events such as nuclear translocation of nuclear factor Kappa B and also on regulation of gene expression using the technique of differential display PCR.